SeattleStatSummer for Biomedical Data Science Research Training

In biomedical research, the need for engaged and well-trained researchers in statistics and data
science has never been greater. Yet, the requisite academic pipeline for training and mentoring
such a workforce remains inadequate. The driving objective of SeattleStatSummer
(SeattleStatSummer for Biomedical Data Science Research Training) is to simultaneously tackle
these obstacles. To address the pipeline problem, we will develop and implement a new summer
mentored research program for undergraduates. The program will offer an engaging and
supportive mentored research experience that increases their awareness of and interest in
pursuing careers in statistics and data science research and career development, community
building, and social/emotional support activities. Our goal is that students will not only gain skills
and confidence in statistics and data science, but they will feel engaged in the statistics and
research communities. The program will also provide coaching to faculty mentors to optimize their
chances of success and confidence in mentoring students and will engage faculty in activities that
build community.
The specific objectives of SeattleStatSummer are Educate through intensive training in R
programming and statistics via an introductory didactic program followed by ongoing
reinforcement and support; Engage: via carefully crafted mentored statistics projects;
Enable: through career development workshops and a role-model program; Endure: foster
ongoing connection and support students in pursuing research careers in the field via activities to
build community and sense of belonging and career support post program. In addition, we
propose to offer a program for faculty mentors that will improve mentoring skills, build confidence
in supervising students, and increase awareness of the importance of fostering a sense
engagement among students.
The Fred Hutchinson Cancer Center and Kaiser Permanente Washington Health Research
Institute offer world-renowned research environments and scientific faculty and prioritize training
the next generation of biomedical researchers. The Puget Sound area is home to a large student
population, which will be targeted for recruitment via a well-honed recruitment plan bolstered by
longstanding academic partnerships.

Public health relevance
In biomedical research, the need for researchers in statistics and data science has never been greater, but the requisite academic pipeline for training such a workforce remains inadequate. SeattleStatSummer (SeattleStatSummer for Biomedical Data Science Research Training) is a summer mentored research program for undergraduate students, and will include an engaging and supportive mentored research experience along with career development, community building, and social/emotional support activities to encourage students to gain skills and confidence in statistics and data science and feel a sense of engagement in the statistics and research communities. The goal of SeattleStatSummer will be to promote a engaged and well trained workforce of future biomedical researchers.